Gene regulatory programs underlying differences in neural crest developmental potential in the head and neck

Proposal Summary
The neural crest is an embryonic cell population which gives rise to varied derivates along the developing
vertebrate body axis. Neural crest from the cranial region forms the craniofacial skeleton, while subunits of the
adjacent vagal neural crest form parts of cardiac mesenchyme and the enteric nervous system. The physical
boundaries between these regions have been established via quail-chick grafting experiments which
demonstrate that, prior to neural crest emigration from the neural tube, the fates of each region are non-
interchangeable. Few previous studies have assessed gene regulation differences by subregion to explain this
phenomenon, and even fewer have looked at single-cell resolution or at premigratory stages. We aim to address
this gap in knowledge by using high-resolution modern techniques to interrogate the subtle differences
in gene expression and regulation between the cranial, cardiac, and enteric subregions of the
premigratory neural crest in the head and neck. We hypothesize that slight modifications in gene expression
programs between these neighboring populations may be amplified in order to bias each subpopulation to a
unique, non-interchangeable fate. Ultimately, this work will aid in our understanding of the mechanisms which
establish fate boundaries between neural crest subpopulations of varying axial levels, leading to the loss of
ectomesenchymal potential in more posterior regions of the body.
Aim 1: Transcriptional profiling of premigratory head and neck neural crest. Previous work to address the
transcriptional state of neural crest in the head and neck has typically taken a bulk-sequencing approach, worked
at migratory stages, or pooled cells from multiple axial levels. Here, we propose using a plate-based single-cell
RNA sequencing method on premigratory neural crest cells at cranial versus cardiac versus enteric axial levels.
We will identify transcription factors which are differentially expressed in the neural crest between these levels
and assess their role in regulating cell fates from our regions of interest.
Aim 2: Determine transcriptional regulation controlling boundary setting in premigratory head and neck
neural crest. Previous studies on regulatory circuits within the premigratory neural crest have primarily focused
on cranial neural crest. We aim to understand the differences in transcriptional regulation before emigration
which establish different fate potentials. We will perform ATAC-sequencing on premigratory neural crest cells
from the cardiac and enteric regions to compare with published premigratory cranial crest data. We will identify
putative enhancers for transcription factors of interest and computationally identify their regulatory inputs to
assess differences in gene regulatory circuits across axial levels.

Public health relevance
Project Narrative The neural crest of the head and neck contributes to many essential tissues including the craniofacial skeleton, parts of the cardiac mesenchyme, and the enteric nervous system. The ability of the neural crest to form ectomesenchymal tissue, such as craniofacial cartilage, is lost in lower parts of the body. Further study of the gene regulatory differences that establish these differential cell fates will inform our understanding of the neural crest while carrying potential implications for underlying craniofacial birth defects and regenerative therapies targeted at generation of ectomesenchyme tissue.